PROGNOSTIC VALUE OF THE KOROTKOFF SIGNAL IN ESSENTIAL HYPERTENSION

To determine whether waveform analysis of the Korotkoff signal in uncomplicated mild essential hypertension provides parameters that parallel known echocardiagraphic markers of adverse prognosis.